Intermolecular RNA-RNA interactions in stress granule regulation and disease

Project Summary
Ribonucleoprotein (RNP) granules are membraneless organelles formed from RNA and RNA binding
proteins (RBPs) through biomolecular condensation or liquid-liquid phase separation. Stress granules (SGs) are
prototypical RNP granules, which form transiently under stresses such as arsenite exposure, UV damage, and
viral infection. The unifying thread between these stresses is translation shutdown due to eiF2a phosphorylation,
leading to rapid increases in the concentration of lowly bound cytoplasmic RNA, which coalesces with RBPs to
form SGs. Chronic stress exposures or mutations in SG RBPs lead to constitutive SGs that behave more like
aggregates than condensates. These stable SGs correlate with poor health outcomes such as aging, asthma,
amyotrophic lateral sclerosis, frontotemporal dementia, muscular dystrophy, and cancer. Thus, understanding
the mechanisms regulating SGs and their functional roles in the cell is paramount to treating disease and
promoting extended health spans.
Though SGs are known to involve extensive networks of protein-protein and protein-RNA interactions, it
remains poorly understood how intermolecular RNA-RNA interactions contribute to SG organization and function.
Therefore, the proposed research objectives focus on determining how the SG scaffolding protein G3BP1
facilitates the formation of intermolecular RNA-RNA interactions, what RNA elements compose these
interactions, and how the cell mitigates stable RNA-RNA interactions during normal cell function of stress
recovery to prevent progression into disease states. In this work, approaches using biochemical, transcriptomic,
high-throughput genetic screens, and cancer cell progression models will 1) determine the biochemical features
required for RNP granule scaffolding proteins to form intermolecular RNA-RNA interactions and their impacts on
stress response, 2) characterize the RNA elements involved in forming stable RNP granule RNA networks, and
3) identify the cohort of proteins responsible for limiting intermolecular RNA-RNA interactions and their roles in
preventing progression from healthy to disease states.
In the K99 phase, mentorship from Dr. Roy Parker and Dr. Robin Dowell will provide valuable training in
biochemical and high-throughput sequencing techniques required to determine the mechanisms and features
driving RNA network formation within stress granules. Further support from Dr. Jennifer DeLuca will provide skills
in working with cancer progression models to determine the functional effects of SG RNA network dysregulation.
The training in biochemical, sequencing, computational, and cell-biological techniques during the K99 phase will
be essential to the proposed research and develop valuable skills required for the independent R00 phase.
Ultimately, the results from this proposal will advance our understanding of SGs and RNP granules
generally by revealing the fundamental role of RNA-RNA interactions in granule organization and maintenance.

Public health relevance
Project Narrative The role of ribonucleoprotein (RNP) granules in organizing cellular function is an area of intense focus, with innumerable studies demonstrating a role for protein-protein and protein-RNA interactions in facilitating the organization of RNP granules through liquid-liquid phase separation, though the role of RNA-RNA interactions remains poorly studied. This study directly examines the mechanisms of formation and dissolution of intermolecular RNA-RNA interactions in stress-induced RNP granules. The proposed research will show how intermolecular RNA-RNA interactions form through specific RNA elements and proteins in RNP granules, identify proteins responsible for limiting RNA-RNA interactions, and characterize the role of RNA-RNA interactions in cancer development.